Protein Kinase C Signaling Mechanisms in Cancer

DESCRIPTION (provided by applicant): The long-term goals of this competing renewal are to elucidate protein kinase C (PKC) signaling mechanisms that contribute to cancer and translate these mechanistic insights into better prognostic and treatment strategies. During the current funding period, we identified PKCι as a human oncogene in non-small cell lung cancer (NSCLC), the number one cancer killer in the United States. PKCι drives anchorage-independent growth and invasion in NSCLC cells by forming a protein-protein complex with the adaptor molecule Par6. The PKCι-Par6 complex activates the Rho family GTPase Rac1 to induce expression of matrix metalloproteinase10 (MMP10). MMP10 is a critical effector of the PKC9-Par6-Rac1 signaling axis and is required for anchorage-independent growth and invasion in vitro. These mechanistic studies informed the design of a rational drug screening strategy which identified the first PKCι-targeted drug, aurothiomalate (ATM) which is currently in Phase I clinical trials for treatment of lung cancer. In this application, we will address three major aspects of oncogenic PKCι signaling. First, we will determine how PKCι activates Rac1. Preliminary data indicate that the Rac-GEF Ect2 regulates Rac1, is required for NSCLC cell transformation, associates with the oncogenic PKCι-Par6 complex and is phosphorylated by PKCι. In Specific Aim 1 we will test the hypothesis that Ect2 is a critical effector of oncogenic PKCι and that PKCι-mediated phosphorylation regulates the oncogenic activity of Ect2. Completion of this aim will provide a novel functional link between Ect2 and PKCι. Second, we will assess whether the oncogenic PKCι signaling axis we defined in NSCLC cells in vitro is required for NSCLC tumor growth and metastasis in vivo. In Specific Aim 2, we will test the hypothesis that the PKCι-Par6-Ect2-Rac1-MMP10 signaling axis is necessary for NSCLC tumor growth and metastasis in vivo. We will establish novel orthotopic NSCLC tumor models to assess the role of key components of this signaling axis in vivo. Third, we will determine whether MMP10 is required for lung carcinogenesis in vivo. Preliminary data demonstrate that PKCι is required for lung carcinogenesis induced by oncogenic K-ras in vivo. In Specific Aim 3 we will test the hypothesis that MMP10 is a critical effector of PKCι in K-ras-mediated lung carcinogenesis in vivo. We will establish novel transgenic mouse models to assess whether MMP10 can drive spontaneous lung carcinogenesis, exacerbate K-ras-mediated lung carcinogenesis and/or restore K-ras-mediated lung carcinogenesis in mice lacking PKCι. Completion of these aims will provide critical new insight into oncogenic PKCι signaling, establish the role of Ect2 in NSCLC, assess the importance of oncogenic PKCι signaling in relevant preclinical NSCLC models in vivo, and determine if MMP10 is a critical mediator of lung carcinogenesis in vivo. These studies will likely reveal Ect2 and MMP10 as novel therapeutic targets for development of therapeutics for treatment of lung cancer. PUBLIC HEALTH RELEVANCE: Lung cancer is the number one cause of cancer death in the United States. Protein kinase Cι (PKCι) is an oncogene, prognostic marker and therapeutic target in lung cancer. This project will elucidate the PKCι signaling mechanisms that drive lung cancer growth and assess the importance of PKCι signaling in lung cancer development, progression and spread in pre-clinical animal models in vivo.

Public health relevance
Project Narrative Lung cancer is the number one cause of cancer death in the United States. Protein kinase Cι (PKCι) is an oncogene, prognostic marker and therapeutic target in lung cancer. This project will elucidate the PKCι signaling mechanisms that drive lung cancer growth and assess the importance of PKCι signaling in lung cancer development, progression and spread in pre-clinical animal models in vivo.